Alcohol metabolism and disease risk in Asians: Examining the impact of personalized phenotypic/genotypic feedback on early drinking trajectories

The alcohol metabolizing gene ALDH2 encodes the enzyme that converts acetaldehyde into acetate during the
metabolism of alcohol. The variant ALDH2*2 allele slows the conversion of acetaldehyde and results in
heightened and protracted exposure to acetaldehyde, which is a known carcinogen. ALDH2*2 is found almost
exclusively in individuals of east Asian descent (estimated in 560+ million people worldwide), and results in a
flushing response from drinking (i.e., “Asian glow”). Although possession of ALDH2*2 is protective against heavy
drinking and alcohol use disorders, for those who do drink, it is also associated with striking elevations in risk for
several cancers, including esophageal and head and neck cancers. This cancer risk, however, is not widely
known outside of the research community. The premise of this study is that we can affect early drinking
trajectories through personalized communication about these cancer risks. This work builds upon two prior
studies we conducted providing personalized feedback to Asian American college students, including an R21
exploratory/developmental study in which we developed and piloted interventions that we further investigate in
this R01 study. These interventions showed sustained effects over a 10-month follow-up period on self-reported
decreased frequency and quantity of alcohol use and increased use of protective behavior strategies (slowing
pace, setting limits). In this study, we will assess 450 college students of northeast Asian descent, a high-risk
group as college is a time of escalating alcohol consumption. It is also a context in which a risk-communications
intervention, if successful, could be readily scaled-up. We will compare phenotypic risk communication with and
without personalized genotype feedback by randomizing participants into one of three groups: 1) a group
receiving information about cancer risk associated with alcohol consumption and alcohol metabolism genetic
deficiencies that manifest as flushing, plus personalized flushing (i.e. phenotype) feedback (PHEN), 2) a group
receiving the PHEN information plus personalized genotype (i.e. ALDH2) feedback (PHEN+GENE), or 3) a
comparison attention CONTROL group. Post-intervention, participants will be followed for 3 years in annual
surveys as well as quarterly surveys of retrospective drinking and 9-day "bursts" of daily reporting on past-day
drinking behavior. In Aim 1, we will test whether the intervention reduces alcohol consumption. We also will test
if genotype feedback results in a greater attenuation of drinking than general risk information and phenotype
feedback only, and if the impact is stronger in those at greater risk based on their phenotype and/or genotype.
In Aim 2, we will test if the interventions also increase the use of protective behavioral strategies and decrease
the use of “flush cures” that reduce visible signs of flushing but not acetaldehyde levels. In Aim 3, we will examine
potential mediators as underlying mechanisms of behavior change and explore possible moderators of
intervention impact. Results of this work may inform intervention/prevention efforts on how to optimally target
personalized feedback protocols for high-risk college samples and scale these at a national level.

Public health relevance
Narrative More than 500 million people worldwide have a genetic variant that affects alcohol metabolism, causes flushing (i.e., the “Asian glow”), and makes alcohol consumption toxic and more cancer causing. We will determine whether informing college students of the implications of the flushing response and telling them if they have this genetic variant will lead them to drink less or in healthier ways. We also will examine if certain factors like risk and benefit expectancies and future thinking are underlying why behavior changes in response to this information about cancer and disease risk. Such knowledge can translate into more effective targeted intervention efforts to reduce modifiable behaviors (e.g., alcohol consumption) that interact with genetic risk factors to increase the likelihood of developing alcohol-related diseases.